Optimizing Technology Uptake and Use in Hard to Reach Adolescents with Type 1 Diabetes

PROJECT SUMMARY/ABSTRACT
Young adolescents (ages 10-15) with type 1 diabetes (T1D) are at high risk for deterioration of glycemic control
and relatedly poor overall T1D self-management. Continuous glucose monitors (CGM) provide real-time
indicators of glucose levels and alert users to hypoglycemia and hyperglycemia. Consistent, informed use of
CGM has the potential to improve glycemic control and related T1D health outcomes. However, adolescents
with T1D are the least likely age group to utilize CGM and significant health disparities exist in access to and
use of CGM among youth from racial and ethnic minority backgrounds and youth with public insurance.
Adolescent CGM users also continue to evidence A1c levels above recommended targets, potentially due
challenges related to perceived CGM burden and related family functioning. Novel, developmentally targeted
interventions delivered early in adolescence could promote optimal uptake and use of CGM and reduce
psychosocial barriers to sustained use but must be evaluated in rigorous pilot trials that attend to health
disparities. The current study proposes to evaluate an innovative behavioral intervention that utilizes certified
diabetes care and education specialists (CDCES) to teach problem-solving and communication skills around
CGM data and use, targeting adolescent-parent T1D interactions related to glucose data, individualized CGM
challenges, and weekly adolescent-parent joint review of CGM reports. The intervention also addresses HCP
knowledge of health disparities in diabetes technology through interactive education, and boosts family support
through connection with peer parent consultants. This study aims to evaluate the preliminary efficacy of the
behavioral intervention to enhance CGM use and resulting T1D health outcomes. Sixty adolescents and their
parents will be recruited for this pilot randomized trial, randomly assigned to either an immediate intervention
group or a delayed intervention group serving as a standard care comparison. Intervention content will be
delivered via 3 telemedicine sessions with adolescents and a parent and supported by connection with a peer
parent consultant. Medical and psychosocial data (including A1c, CGM indicators, CGM burdens and benefits,
diabetes distress, and diabetes-related family conflict) will be collected from adolescents and a parent at
baseline and three follow-up time points across the first year after CGM initiation. We will employ quantitative
and qualitative analyses to evaluate intervention feasibility, acceptability, and impact. Enhancing CGM access
and use at this key developmental juncture provides an excellent opportunity for tailored support and problem-
solving, resulting in potentially lasting improvement in diabetes self-management. Results of this pilot trial will
directly inform a multi-site randomized clinical trial to evaluate efficacy, with the long term goal of identifying
effective behavioral strategies that can be integrated into routine diabetes education and care.

Public health relevance
PROJECT NARRATIVE Advances in diabetes technology such as continuous glucose monitors (CGM) have the potential improve health outcomes for youth with type 1 diabetes, but adolescents are the least likely to use CGM, are at relatively high risk for underutilizing or discontinuing this technology, and access is challenged by significant health disparities. This project proposes to pilot an intervention incorporating behavioral strategies to optimize CGM use and reduce related psychosocial barriers. The findings of this pilot work will initiate a trajectory of research responsive to the needs of young adolescents, including youth from historically underrepresented racial and ethnic backgrounds and youth with public insurance, related to new diabetes technologies with significant potential to improve health outcomes and clinical diabetes education and care.